Learning biophysical principles ofcellular organization

PROJECT SUMMARY
This project addresses emergent collective behavior in living systems at two different scales, communities of
bacteria and intracellular biomolecular condensates: (1) Beyond living together, bacteria communicate with each
other using a process known as quorum sensing that relies on the production, detection, and response to
diffusible signal molecules called autoinducers. Quorum sensing provides bacteria with information about their
local cell density and the species complexity of their environment. Bacteria use the information they gather to
beneficially control collective behaviors. Quorum sensing has been extensively studied in the laboratory. My goal
is to understand how quorum-sensing operates in natural environments. How do the complex spatial structure
and temporal dynamics of bacterial communities affect the strategies by which bacteria obtain and exploit
quorum-sensing information? How does the presence of other species influence quorum sensing? The latter
question has been brought to the fore by the observation that both eukaryotic hosts and bacterial viruses (phage)
participate in quorum-sensing conversations with bacteria. The ubiquity of quorum sensing in the bacterial world
implies that answers to these questions, even in specific contexts, have the potential to provide broad insights
into microbial collective behavior across species and environments. (2) Phase separation is an emerging
organizing principle for intracellular biology. Processes that are now understood to exploit phase separation
include storage of genetic material, gene expression, ribosome synthesis, signaling, stress response, and
metabolism. While each phase-separating system has unique features, there are universal questions relevant to
all such systems. E.g., what controls the number, size, and location of condensates within a cell? By what
mechanism(s) are particular components included while others are excluded from condensates? How do cells
orchestrate physical interactions between condensates and other cellular structures? To address these
questions, I will focus on a well-suited model organism and system: the genetically tractable alga
Chlamydomonas reinhardtii and its pyrenoid, a phase-separated organelle responsible for efficient carbon
fixation. Key advantages of this system are that phase separation of the pyrenoid is driven by two well-
characterized components, the condensate’s in vivo liquidity is reproduced in vitro with no energy source, in vivo
assembly/disassembly is controllable by external cues, and the pyrenoid is a single body that is both large and
stable enough to systematically investigate its functional interactions with other cellular components including a
network of membrane tubules. I anticipate that by focusing on underlying biophysical mechanisms, the results
of these studies will generalize to a wide range of phase-separated intracellular systems.

Public health relevance
PROJECT NARRATIVE One theme of this project is to investigate the role of bacterial communication under conditions that closely mimic natural environments, including flow, time dependence, spatial structure (e.g. biofilms), and the presence of other organisms including eukaryotes and viruses (phage). The second theme is to define the biophysical principles underlying the function of intracellular, non-membrane-bound compartments, called condensates, which are now appreciated to play ubiquitous roles in molecular processing, storage, signaling, and metabolism. These studies, because they are performed on tractable model systems, hold promise to reveal insights into general properties that emerge at the scale of collectives of cells and at the scale of collectives of molecules.